Center for HIV Identification, Prevention and Treatment Services

ABSTRACT - OVERALL
The Center for HIV Identification, Prevention, and Treatment Services (CHIPTS) proposes an HIV/AIDS
research agenda aimed to reduce HIV transmissions. CHIPTS promotes science, networking, and capacity
building to aid viral suppression for people with HIV (PWH) and reduces HIV infections for those at-risk, for
those living with mental health and substance use disorders and barriers to social and structural determinants
of health (which we termed as comorbidities). CHIPTS is a collaboration of leading scientists from UCLA,
Charles Drew University, Friends Research Institute, and RAND Corporation. Five research themes are
proposed: (1) guide a Southern California regional strategy to End the HIV Epidemic; (2) stimulate HIV
prevention research that addresses comorbidities among key populations in U.S. and globally (MSM of color,
transgender women, etc.); (3) catalyze multi-level combination behavioral, biomedical, technological and
structural prevention research; (4) promote diversity, demand equity and support inclusion in the developing
the next generation of HIV science and HIV scientists; and (5) create innovative methods to advance these
themes. The specific aims are: (1) Science: To promote novel, high impact and transformational research that
disrupts barriers to implementation, uptake, adherence, and persistence across HIV prevention, care, and
policy continua in key populations simultaneously affected by comorbidities; (2) Networking: To facilitate
collaboration among scientists, providers, policy makers and stakeholders from affected and at-risk
communities to support the next generation of HIV prevention science and scientists; (3) Capacity Building: To
promote diversity and equity as we mentor and train researchers, policy makers, providers, community leaders
and staff members in mental health, social service, criminal justice, social justice, public health, and
administrative systems regarding comorbidities to HIV. CHIPTS is comprised of five cores: (1) Administrative
Core, which sets the scientific agenda, leads the interdisciplinary team, prioritize and coordinates the center's
activities; It manages administrative and financial functions, leads strategic planning, evaluates center's
progress, and houses a cross-disciplinary Global HIV Prevention Program. (2) Development Core, which
provides mentored opportunities to invest in emerging investigators with diverse backgrounds to generate
multi-disciplinary HIV prevention science; (3) Combination Prevention Core, which facilitates research, brokers
collaborations, promotes combination behavioral, biomedical, technological and structural HIV prevention
science; (4) Methods Core, which guides innovation in measurement, statistical methods for multiple outcomes
for people with or at risk for HIV; (5) Policy Impact Core, which impacts public health by infusing policy
considerations into research design, promotes findings to influence policy making, and contextualizes scientific
discoveries to guide future policy decisions and implementations at local, national, and international levels.

Public health relevance
PROJECT NARRATIVE In the United States and especially in Southern California, new cases of HIV continue to accrue, especially among those who identify as having minority racial/ethnic and/or sexual/gender status. New approaches that integrate combination biomedical, behavioral, technological and structural interventions offer exciting possibilities to significantly reduce HIV transmission, especially in key populations of people living with HIV or at risk with co-occurring mental health and substance use disorders and/or barriers in access to social and structural determinants of health. The Center for HIV Identification, Prevention, and Treatment Services (CHIPTS) mobilizes world class leaders and affected communities in the areas of science, networking and capacity building to lead the HIV prevention agenda both in the U.S. and internationally, particularly in addressing these comorbidities among those living with or at risk for HIV.